ASCORBATE EFFECT ON LDL OXIDATION AND IRON STATUS IN SMOKERS

The primary objective of this study is to assess the effect of in vivo supplementation with ascorbate on LDL oxidation in a randomized, placebo-controlled outpatient study of smoker. As an auxiliary aim, the effect of 1 g/day ascorbate supplementation on various measures of iron status in these individuals will also be studied.